PSYCHOSOCIAL PREDICTORS OF MENTAL AND PHYSICAL HEALTH

Normal personality dimensions can predispose individuals to certain forms of psychopathology, especially personality disorders. Studies in two samples examined relations between personality dimensions of the standard five-factor model and an alternative model designed specifically to capture dimensions of psychopathology. Correlations between the two models showed both overlapping and unique features; both sets of dimensions were useful in predicting personality disorder symptoms in a clinical sample. Efforts to relate basic research on personality to applications in clinical psychology and studies of the relation of personality to physical health will continue.